Mitochondrial regulation and function in cancer and cardiovascular biology

Our laboratory is interested in the regulation of the mitochondria by factors such as p53 and WASF3, and how they can impact disease pathogenesis. To this end, we have studied Li-Fraumeni syndrome (LFS), an early onset cancer disorder caused by germline mutations in the TP53 gene, and chronic fatigue syndrome (ME/CFS) using both mouse models and translational studies. Our investigations have yielded insights potentially useful for developing new treatment strategies. We will continue performing bench to bedside investigations on a novel mediator of chronic fatigue that we have identified.